2023 NINDS Landis Mentoring Award

Our long-term goal is to understand the brain rhythms underlying specific signs and symptoms of
movement disorders at fast time scales, determine the effects of deep brain stimulation (DBS) on these brain
rhythms, and utilize this knowledge to develop closed loop or “adaptive” stimulation. DBS of the globus pallidus
(GP) is increasingly performed for Parkinson's disease (PD), based on its greater safety with respect to
cognition and mood compared with subthalamic nucleus (STN) DBS, but its mechanism is not well understood.
Invasive field potential recordings in the basal ganglia in humans has led to the influential hypothesis that
specific patterns of abnormal oscillatory synchronization underlie the motor signs of PD. Abnormal rhythms in
the beta band (13-30 Hz) are thought to be “antikinetic” while higher frequency (60-90 Hz) rhythms are
“prokinetic.” Other frequencies may be “tremorogenic”. Our general approach is to extend this conceptual
foundation to motor cortex and utilize network analyses from simultaneous cortical and subcortical recordings.
In the initial grant period 2014-18, we focused on STN and its cortical interactions. Here, we will study
pallidal and pallidocortical responses to levodopa and pallidal DBS, utilizing the technical approach developed
in the previous grant period: chronic multisite field potential recording from basal ganglia and cortical
electrodes, utilizing a totally implantable bidirectional neural interface. We employ a newly available second
generation interface, RC+S (Medtronic) which holds substantial advantages with respect to recording quality
and programmability over the first generation device (PC+S). We will use this device to understand
electrophysiologic effects of antiparkinsonian medications (Aim 1) and of therapeutic pallidal DBS (Aim 2) on
the basal-ganglia thalamocortical circuit; and build on these results to prototype algorithms for adaptive
stimulation in which brain signals are utilized to adjust stimulation parameters according to changing brain
needs (Aim 3). In addition to in-clinic recordings in defined medication states (on or off), we will use home
recordings, with continuous “data streaming” from the implanted device and from wearable monitors, to
increase the odds of biomarker identification.
The impact of these studies will be to: 1) Provide a mechanistic understanding of the effects of
therapeutic pallidal DBS on the basal ganglia-thalamocortical circuit. This may translate into improved
physiological criteria for electrode placement and to rational and streamlined programing strategies. 2) Create
a foundation for the development of “adaptive” DBS, perhaps the first major technical advance in DBS therapy
since its introduction 25 years ago. 3) Develop a novel paradigm in human neuroscience, that of chronic
ambulatory brain network recording in totally naturalistic environments, providing a platform for answering
fundamental questions on basal ganglia-cortical interactions. Mechanisms elucidated in this study may be
applicable to other disorders of brain circuits for which DBS has shown therapeutic promise.

Public health relevance
Deep brain stimulation (DBS) is increasingly used to treat Parkinson's disease (PD), but there is limited understanding of how it works, impeding improvements in this therapy. Here, in patients requiring DBS of the globus pallidus for PD, we will implant a novel type of brain stimulator that senses brain activity and streams it wirelessly to an external computer, as well as delivering standard DBS therapy. We will analyze brain signals from both deep and surface structures to understand how specific electrical rhythms relate to specific motor signs, and to develop a new form of DBS that uses brain signals to respond adaptively and automatically to changes in motor function.